O-polysaccharide (OPS)-IpaB Conjugate Vaccine to Prevent Shigellosis

RESEARCH SUMMARY
Shigella causes a high burden of dysentery globally. Children younger than 5 years of age, particularly toddlers
2-3 years old, living in impoverished areas lacking clean water and sanitation are the most affected. Repeated
infection results in lifelong health impairment and disability. Shigella also causes outbreaks in industrialized
countries (daycare centers and medical institutions) and is a serious threat due to its multi-drug resistance.
There is no approved vaccine. Most of the existing candidates rely on immunity to the Shigella O-antigen, which
is serotype-specific (there are 4 species and >50 diarrheagenic Shigella serotypes). Shigella O-polysaccharide
(OPS) conjugates (e.g., SF2a-TT15 and Flexyn2a) are the most clinically advanced. These vaccines are limited
in their use of irrelevant (non-Shigella) proteins as carriers. SF2a-TT15 uses tetanus toxoid, which is included in
many vaccines given to children of the target age and is known to suppress responses to other vaccine
components. Flexyn2a uses rEPA as carrier but had modest efficacy in a recent challenge study (did not meet
study endpoints). An earlier S. sonnei OPS-rEPA was effective in older children but not in toddlers (target age).
In response to RFA-AI-22-037, the University of Maryland (UMB), in partnership with Vaxcyte, proposes to
develop a bivalent (Shigella flexneri 2a and Shigella sonnei) OPS conjugate vaccine using Shigella IpaB, a Type
III secretion protein that is highly conserved among all Shigella spp., as carrier. IpaB is exceptionally
immunogenic and is a known broadly protective antigen; serum IgG (IgG1) levels and IpaB antibody function
were found to be positively associated with reduced disease in controlled human challenge studies.
For the first time, we have produced soluble, immunoreactive IpaB at a high (industrial) yield using Vaxcyte’s
cell-free protein expression system. IpaB is conjugated to S. flex 2a and S. sonnei OPS using Vaxcyte’s site-
specific conjugation technology. S. flex 2a OPS-IpaB given to mice intramuscularly with Alum on two occasions
28 days apart, elicited robust immune responses and afforded 78% protection against S. flex 2a (homologous)
and 56% against S. sonnei (heterologous) lethal pulmonary Shigella challenge. Vaccine efficacy against S. flex
2a was higher as compared with S. flex 2a OPS-conjugated to CRM197 (a diphtheria toxoid mutant).
This proposal consists of three aims to optimize process development, formulation, and scale-up production of
S. flex 2a- and S. sonnei OPS-IpaB conjugates (Aim 1), evaluate the immunogenicity and vaccine efficacy in two
animal models: mice (pulmonary challenge) and guinea pigs (rectocolitis infection) (Aim 2), and identify immune
operatives associated with protective immunity through passive transfer experiments and a suite of in vitro
functional assays (Aim 3). A bivalent Shigella-OPS-IpaB vaccine is expected to be well tolerated and to have
enhanced protective capacity than existing vaccines.
UMB and Vaxcyte have unique complementary expertise. Successful completion of this project will prepare the
vaccine to enter cGMP manufacturing and initiate human studies.

Public health relevance
PROJECT NARRATIVE The goal of this proposal is to advance the pre-clinical development of a broad spectrum Shigella vaccine consisting of Shigella flexneri (S. flex.) 2a, and S. sonnei O-polysaccharide (OPS) conjugated to Shigella IpaB (a highly immunogenic and protective Type III secretion system protein) using innovative technology: cell-free expression of IpaB and precise (site-specific) OPS-IpaB conjugation. S. flex 2a OPS-IpaB elicited robust immune responses in mice and afforded high levels of protection against S. flex 2a and S. sonnei lethal infection; a bivalent S. flex 2a and S. sonnei OPS-IpaB conjugate vaccine is expected to have broad efficacy and cover the most relevant disease-causing serotypes. UMB and Vaxcyte have partnered to refine and scale up vaccine production, assess vaccine efficacy and protective immunity in animal models, and establish cGMP manufacturing procedures in preparation for toxicology studies and clinical evaluation.